Community-Based Participatory Research to Enhance Vaccine Uptake Across the Lifespan through Innovative Points of Access and Altering Norms in Border and Rural Regions

Abstract
Vaccination is a highly effective public health intervention that saves millions of lives per year, yet declination
rates for are increasing in the US for a variety of reasons ranging from safety concerns to religious and
philosophical objection. In the wake of declining vaccination rates associated with the COVID-19 pandemic, the
Chiricahua Community Health Centers, Inc. (CCHCI) in rural southeast Arizona initiated an innovative project
to enhance vaccination through placement of an immunization specialist in dental clinics affiliated with the
federally qualified health center (FQHC) system. The literature suggests that there are multiple salient and
modifiable points to promote vaccine uptake within a multilevel approach that engages adults, adolescents,
providers, families and communities. To enhance vaccine coverage through novel strategies, we propose the
following specific aims: 1) Identify barriers and facilitators to vaccine uptake for specific vaccine types and
populations in rural and border regions through engagement of individuals, communities, providers, and
public health officials; 2) Determine the sustainability of the CCHCI FQHC dental clinic immunization program
and scalability of the intervention to dental clinics at the Mariposa Community Health Center (MCHC) FQHC
clinics in Santa Cruz County; and 3) Implement and evaluate a multilevel intervention to enhance vaccination
uptake in populations unlikely to access FQHC care via an Underserved Population Study Team deployed
through the MHU. Our approach will integrate socioecological and health beliefs model framing to understand
the roles of socioeconomic factors, trust in health systems and public health authorities, and perceptions of
vaccine efficacy and risk. We propose implementation of the dental clinic immunization program at the MCHC
and support for the continuation of the program at CCCHCI. We also propose that staff from both CCHCI and
MCHC work with the study investigators to author an implementation guide, rooted in Normalization Process
Theory and a Dynamic Sustainability Framework, to participate in rigorously evaluating adaptability,
effectiveness, and sustainability of this approach in FQHCs. We will develop, pilot, and assess a multilevel
intervention strategy aimed at improving vaccination rates within populations that face barriers to healthcare
access, particularly those residing in rural and hard-to-reach areas or individuals who do not typically utilize
FQHCs. We will leverage the UA College of Public Health Primary Prevention Mobile Health Unit (MHU)
program as a strategic platform for delivering vaccinations, utilizing community events as key touchpoints for
outreach. At the community level, our focus will be on fostering a supportive environment that promotes
vaccination through education, awareness campaigns, and collaboration with local community leaders.
Simultaneously, at the individual level, the MHU team will provide personalized education, addressing specific
concerns and providing tailored information to encourage vaccine uptake.

Public health relevance
PROJECT NARRATIVE This project will develop, implement, and evaluate a dental clinic intervention and mobile health unit community-based intervention designed to increase the proportion of evidence-based vaccinations among adolescents and adults and improve educational awareness and confidence in vaccinations among US-Mexico border Latinx and rural populations. This project will help to increase the quality and quantity of immunization services research and provide a framework to translate research into practice and policy resulting in increased immunization confidence and uptake. Project findings will contribute to evidence regarding the effectiveness of clinic-based and community-based interventions to address immunization health disparities.